Enhanced environments for psychophysical evaluation and training

Project Summary
Speech in noise tests have traditionally involved 1) unrealistic maskers such as broadband noise presented
from the same spatial location as the target speech, and 2) unengaging reward structures. Our overarching
hypothesis is that the experience of listeners in their daily lives will be more strongly related to performance if
the laboratory tests are enhanced by increasing the realism of the testing environments and introducing game-
like interfaces. The main goal of this project is to determine which enhancements have the greatest impact on
the relationship with listener complaints, and which listener abilities (auditory and cognitive) mediate and
modulate this relationship. Enhanced environments will be tested that 1) simulate real-world experiences by
conducting assessments in synthetic environments that include both auditory and visual stimuli and 2)
introduce game-like elements that are more rewarding and motivating for the listener. Understanding how
different participants respond to a variety of enhancements will provide essential new information about the
ways in which realistic experiences differ from traditional laboratory tests and the ways that rewards and
motivation influence variability of test results as well as relationships with self-report. Experiments will involve
younger listeners with normal hearing, older listeners with a range of hearing abilities from normal to severely
impaired, and a group of listeners with a history of mild traumatic brain injury. These participants will provide a
wide range of performance on measures of auditory and cognitive abilities, which can then be used to better
understand any effects of the enhancements on self-reported ability to function in complex listening
environments. Upon completion of this project there will exist, freely available, an extensive set of enhanced
auditory assessments that are more engaging and more realistic than what is currently available and that run
on inexpensive consumer-grade equipment. This project will establish for these enhanced tests both 1)
established ranges of normal performance as a function of age and hearing loss, and 2) known relationships to
various established tests of speech in noise. The modeling work associated with this project will reveal which
auditory and cognitive abilities are associated with deviations from normal performance and self-reported
difficulties hearing in adverse listening environments that are great than would be expected.

Public health relevance
Project Narrative The goal of this research project is to test the hypothesis that that the experiences of listeners in their daily lives can be more strongly related to performance in a controlled test environment by using enhanced environments involving both virtual reality elements and game-based modifications to the testing procedures. A secondary, and potentially alternative, hypothesis is that the benefit of these enhancements will vary based on individual differences. Upon completion of this project there will exist, freely available, an extensive set of engaging, enhanced auditory assessments with established regions of normal performance as a function of age and hearing loss, and known relationships to various established tests of speech in noise that run on inexpensive consumer-grade equipment.